CLINTRUSC Community Engagement & Outreach Core

CEO-Project Summary
The overarching goal of the Clinical Engagement and Outreach (CEO) Core will be to provide a
unified network of clinical sites throughout the South Carolina Midlands in which clinical and
translational research can be performed. Through engaging expertise at the University of South
Carolina in the colleges of medicine, public health, nursing, pharmacy and social work, the CEO
will address how to overcome barriers in community engagement and patient recruitment.
Specifically, these colleges contain programs in rural community engagement and links to rural
health clinics (Federally Qualified Health Centers (FQHCs)). Prisma HealthCare System
operates 17 primary care clinics within the Midlands, and based upon ZTCA mapping, many of
these are located in areas which contain underrepresented populations- notably a very high
Black population. The Columbia VA in addition to serving a large region of the Midlands in and
of itself, also operates 3 Community Based Outpatient Based Clinics (CBOCs) within the
Midlands. Accordingly, the overarching goal of the CEO Core will be to build upon the strengths
which exist within USC and form an integrated network of health care clinics which will allow for
clinical-translational research capacity within the Midlands and most importantly focus upon
vulnerable patient populations; veterans and underrepresented patients.